Determining reliability and efficacy of intraoperative sensors to reduce structural damage during cochlear implantation

PROJECT SUMMARY
HL is a leading cause of disability worldwide, responsible for an estimated $981B in global
costs. When acoustic amplification of hearing aids is no longer an effective treatment, patients
can receive a cochlear implant (CI). Currently, the surgeon threads the electrode array into the
spiral cochlea, risking structural damage that destroys residual acoustic hearing and impacts
overall hearing outcomes. Consequently, adoption rates remain extremely low: 5% of the eligible
population in the US.
Advanced Optronics (AO) is developing a novel surgeon guidance system using a
microelectromechanical system (MEMS) sensor array that will be seamlessly integrated with
existing CI electrode array designs to detect bending and forces acting on the array to warn
surgeons of potential risks. Using advanced polymer microfabrication techniques, AO has
produced ultra-thin and flexible sensors that can be incorporated into CI electrodes with
minimal impact on the CI electrode size or mechanics.
This Phase I proposal will demonstrate the feasibility of the system from a fabrication,
usability, and regulatory perspective. The Phase I results will pave the way for clinical
translation during Phase II. The Specific Aims for the Phase I project are:
Specific Aim 1: Determining Sensor Reliability with a Cochlear Implant
Electrode: The complete system (CI + Sensor) will be iteratively improved for robustness and
reliability to maximize two key metrics: 1. Measurement reliability, and 2. Attachment
robustness.
Specific Aim 2: Demonstrating Sensor Effectiveness to Improve Surgeon
Technique: The system's efficacy will be validated via surgeon insertion in 3D printed cochlear
models. Surgeons will systematically vary insertion technique and data collected in these trials
will be evaluated to show that real-time feedback allows surgeons to minimize insertion forces.
Specific Aim 3: Determining Regulatory Pathway and Requirements: A detailed
regulatory proposal will be prepared to cover Intended Use, regulatory descriptions of hardware
and software components, and studies to support safety and effectiveness. A Pre-Submission
briefing document will be prepared for an early and comprehensive FDA discussion on product
development and registration strategies.

Public health relevance
PROJECT NARRATIVE Although cochlear implants are highly successful overall, structural damage following the procedure is common, degrading residual hearing and affecting patient outcomes. A patient is likely to see a reduction in their residual acoustic hearing as a side effect following the surgery. This project will develop a novel surgeon guidance system using a sensor that can be integrated with existing cochlear implant electrode designs to detect bending and forces during implantation. The guidance system will provide the surgeon with real-time information to assist them to detect and avoid trauma during the procedure. The success of this SBIR Phase I proposal will enable refinement to the sensor design, surgeon usability, and regulatory strategy so that it can be commercialized as a device to aid implantation for new cochlear implant candidates. In total, this project can allow many more people to regain their connection with the hearing world and enjoy a higher quality of life.